Administrative Work Assignment (WA1)

This WA is to cover the administration of the contract for six months. This WA is to cover the costs to conduct a definitive toxicology study of hsp11 0-gp1 00 chaperone complex in mice.